Role of LRRK2 in immunity in a nonhuman primate model of SIV

Project Summary
While modern therapy has enabled the more than 37 million people living with HIV to experience near normal
life expectancy and transformed it into a manageable chronic disease, neurocognitive impairment remains an
unresolved clinical concern. Increasing evidence indicates that chronic systemic immune activation contributes
to neuroinflammation, and neuroinflammation promotes the severity of neurodegenerative diseases.
Intriguingly, viral-induced neuroinflammation has striking similarities to neurodegenerative disease, and chronic
infection may increase the risk of developing neurodegenerative disease. One factor linked to
neuroinflammation, neurodegeneration, and host immunity against microbial pathogens is the immune kinase
leucine rich repeat kinase 2 (LRRK2). LRRK2 has been implicated in modulating antiviral cytokine activity,
conferring susceptibility to mycobacterial infection, and mutated LRRK2 is the most common monogenetic
cause of the neurodegenerative disorder Parkinson’s disease. The long-term objectives of this proposal are to
extend the observation that LRRK2 modulates antiviral immunity during bacterial infection to determine the
function of LRRK2 in viral pathogenesis and neuroinflammation and assess its therapeutic potential. Using a
macaque SIV infection model for HIV, this proposal seeks to address the fundamental questions of whether
SIV infection promotes LRRK2 expression, and how loss of LRRK2 impacts SIV pathogenesis and the host
immune response. We hypothesize that LRRK2 contributes to HIV pathogenesis through regulation of antiviral
immunity. To test this, we will use a non-human primate (NHP) model to assess the impact of SIV infection on
LRRK2 gene expression and protein levels longitudinally in circulating immune populations and gastrointestinal
tract, and at a single time point in the brain as LRRK2 is dynamically expressed in these tissues. Next, we will
assess the impact of LRRK2 inhibition on host response to SIV using both in vivo and ex vivo approaches. The
data obtained by this project will shed light on the function of LRRK2 in antiviral immune activation and
generate preliminary data for future studies investigating factors contributing to viral-induced
neuroinflammation. The proposed study and Mentored Career Development Plan will be conducted at Tulane
National Primate Center (TNPRC) under the guidance of Drs. Tracy Fisher and Ronald Veazey, experts in viral
induced neuroinflammation and SIV pathogenesis. The TNPRC is a national resource for NHP biomedical
research with a long history of research excellence in viral pathogenesis and therapeutic intervention. The
TNPRC has a strong commitment to training and mentorship demonstrated by extensive financial, effort-
based, and programmatic support to cultivate a rich and diverse training environment for early-stage
investigators. The mentored support and dedicated time provided by the K01 will further Dr. Vail’s career goals
of becoming an independent investigator and NHP researcher studying host pathogen interactions.

Public health relevance
Project Narrative Nearly 38 million individuals worldwide live with HIV, a chronic viral infection associated with neuroinflammation. Chronic infection and neuroinflammation heighten the risk of neurodegenerative disorders linked to genetic mutations such as those in the Parkinson’s disease gene, LRRK2, which modulates the body’s response to bacterial infection. The proposed research will determine the role LRRK2 plays in the immune response to viral infection and contribute to our understanding of the biological consequences of LRRK2 blockade during early stages of HIV.